Project 1: Streamlined identification of PAHs/PACs in environmental samples using ultracompact spectroscopy platforms and machine learning strategies

Project Summary
Exposure to polycyclic aromatic hydrocarbons (PAHs) and associated polycyclic aromatic compounds
(PACs) has long been identified with a large number of human health risks. PAHs are well-known carcinogens
and mutagens. Current analytical techniques for detection of PAHs and PAC are laboratory based, slow,
complex, and require expensive instrumentation and sample preparation. We propose an entirely new approach
combining optical spectroscopic techniques such as Surface Enhanced Raman Spectroscopy (SERS) and
Surface Enhanced Infrared Absorption (SEIRA). These techniques can also be combined onto a single
nanoengineered substrate, designed to sensitively identify specific PACs. While these techniques have been
demonstrated successfully using gold and silver based nanoparticles and nanoengineered substrates, we
propose to expand these techniques using inexpensive and environmentally friendly Aluminum nanoengineered
substrates for streamlined ultrasensitive PAH and PAC detection. This platform will utilize polydopamine, a
biomimetic polymer inspired by mussel adhesive proteins, as coatings for molecular partitioning, selectively
extracting and adsorbing PAH and PAC molecules from samples of interest onto the nanosensing substrates. In
preliminary results, this approach has yielded sub-ppb detection sensitivities for PAH molecules extracted from
liquid samples. Furthermore we propose to design and demonstrate a new type of chemical detector that can
be fully integrated with SERS and/or SEIRA substrates, to directly generate an electrical signal in response to
the spectrum of the PAH and PAC molecules. This would eliminate the need for bulky and expensive
monochromators and dispersive optics, ultimately allowing for the design of ultracompact, “on-chip” detectors
that can be deployed in the field at superfund sites and in the clinic. Prototypes of this type of direct spectral
detector have recently been demonstrated by our group. We will also address one of the primary problems
universal to analyte detection and analysis, the detection of chemical mixtures, likely to be found under actual
field sampling conditions, by applying a machine learning approach. We propose to develop machine learning
algorithms that automatically analyze the spectra of multicomponent samples, trained to identify with high
accuracy and precision their PAH and PAC components. The ultimate outcome of this project is the creation of
a streamlined, ultracompact, ultrasensitive chemical analysis and detection platform, capable of identifying
multiple PAHs and PACs in a single sample without costly separation and purification steps, which could be
readily transitioned to fieldable use.

Public health relevance
Project narrative The goal of this project is to achieve detection sensitivities similar to analytical techniques such as GC-MS, using new, nanoengineering-based approaches to chemical detection and identification of PAHs and PACs based on surface-enhanced vibrational spectroscopies. Combining the optically active nanoengineered substrates with ultracompact photocurrent detection technology, could greatly facilitate and accelerate the evaluation of superfund sites and their environmental and biological impact, and will also help in risk assessment by partnering with EPA and ATSDR.